BU-UL Partnership to Enhance Emerging Epidemic Virus Research in Liberia (BULEEVR)

Abstract
The 2013-2016 Ebola Virus Disease (EVD) Epidemic in West Africa revealed the dire need for improved
regional capacity for research in emerging infectious diseases. Despite the heavy human toll of the epidemic,
by the time the research infrastructure was in place to ethically and appropriately test new diagnostics and
medical countermeasures, the epidemic was waning. Liberia, one of the countries affected by the recent EVD
epidemic, has a severe dearth of scientific capacity although recently founded research consortiums related to
EVD in country have created a potential platform upon which further programs can be built. Fostering
education and infrastructure for research in West Africa in general, and Liberia specifically, will have multifold
benefits. First, it will increase the rapidity of trials when an outbreak occurs due to preset protocols,
agreements and trainings in country. Second, the long term central involvement of national researchers will
promote community trust and engagement, aiding successful execution of trials. Third, research infrastructure
built to support emerging pathogens will address other endemic infectious diseases. Lastly, promoting and
advancing West African scientists allows investigator based applications to reflect regional and local research
agenda. The foundation for success of all of the above activities is a pipeline for the creation of the next
generation of Liberian investigators.
Boston University (BU) and University of Liberia (UL), along with regional partners propose the creation of a
tiered research training program in emerging infectious diseases, entitled “Boston University-University of
Liberia Emerging Epidemic Viruses Research” (BULEEVR) program, the framework of which is based on their
on-going partnership and extensive needs assessment performed under a D71 planning awarded to the project
in 2017-2018. The BULEEVR program will advance candidates with a prior Masters degree towards a doctoral
degree and medical school graduates through a Masters in Science. In addition to generating investigators
with the appropriate training and experience in addition to a terminal degree (who can eventually apply for
independent funding), the program will foster mentored research for participants in ongoing research projects
in Liberia, hence building both sustainability and retention of intellectual capital in country. The BULEEVR
program will consist of a bootcamp held in Liberia which will provide a background in foundations of basic,
translational and clinical research and will serve as a the recruitment pool from which small select program of
candidates can then pursue an advanced degree at BU. The candidates will then return to Liberia for their
research experience. The bootcamps will be open to both candidates interested in pursuing an advanced
degree as well as other research professionals interested in expanding their skills or knowledge base, or to
cross-train in a new methodology through a specific offered module.

Public health relevance
Public Health Significance Fostering Liberian researchers will allow the country to more readily combat novel infectious diseases outbreaks through discovery of appropriate timely science. By creating a program which provides a basic background in research through bootcamps in Liberia and then trains small number of qualified participants who will pursue an advanced degree in related scientific field at Boston University, the “Boston University- University of Liberia Emerging Epidemic Viruses Research” (BULEEVR) program will create human resources critical to building research capacity in Liberia.